Noninvasive sleep enhancement and behavior monitoring technologies for Alzheimer's model mice

The aims of this project are to develop new technologies to identify and track sleep and wake
abnormalities present in mouse models of Alzheimer’s disease (AD), as well as to test a sleep enhancement
technology for applications in AD animal research. Signal Solutions, LLC, has previously developed and
commercialized a piezoelectric based system for noninvasive, high-throughput sleep and wake monitoring of
rodents. Automated scoring of sleep and wake allows for simultaneous recordings of many animals over longer
periods, with little burden on the researcher, rivalling EEG/EMG methods that are more complicated and
expensive to perform.
Behavioral changes in sleep and wake can precede memory loss in the progression of Alzheimer’s
disease (AD). Clinical studies suggest sleep disturbances are exhibited in a high percentage of AD patients.
Animal models of AD also display sleep disturbances and some models show changes in wake behaviors
before the molecular hallmarks and memory problems appear, as clearly occurs in human AD. In the treatment
of AD, a potential therapeutic target is preventing the aggregation of pathogenic forms of amyloid-beta (A-beta)
and tau. Waste clearance in the brain has been shown to be increased with increased sleep, including
clearance of A-beta. Recently, non-pharmacological approaches using mechanical devices for rocking have
shown promise for sleep enhancement, which could be applied to AD research.
The specific aims of this project are to 1) Develop advanced sleep/wake tracking technology: Add a
new multipoint touch sensor to our current piezoelectric technology that together will identify specific behaviors
associated with AD progression, tested with AD mouse model 3xTg. 2) Develop Sleep Enhancement
Technology: Modify our current MouseQwake sleep-disruption system for mechanical sleep-enhancement,
with companion sleep and wake tracking capabilities.
Anticipated Outcomes: The envisioned product is a home cage sensor and software that will allow
researchers to accurately measure changes in sleep and wake during long-term AD disease progression, as
well as track subtle changes in behavior in AD model mice. This system will minimize the amount of work, time
testing behaviors, and time for analyzing the videos or electrophysiology that is currently a major bottleneck.
An expanded MouseQwake system will provide a tool for sleep manipulation of both sleep enhancement and
disruption as well as simultaneous sleep/wake and behavioral recording. If successful, a Phase II investigation
will involve large scale studies of multiple AD rodent models, and continue iterative improvements to both
hardware and software developed in phase I.

Public health relevance
Sleep disruption is now recognized not only as an early symptom of Alzheimer’s Disease (AD), but also a contributor to its ongoing development, and thus sleep enhancement is a promising approach to slow the disease. This proposal intends to provide new technology to facilitate preclinical studies in AD model mice, including long term monitoring of behaviors associated with disease progression, and a new method to manipulate and enhance sleep in mice to assess effects on disease and interventions.